Project 1: Improved Targeting of EGFR Family Members in Squamous Cell Carcinomas of the Head and Neck

SUMMARY
The epidermal growth factor receptor (EGFR) remains the only validated molecular target in head and neck
squamous cell carcinoma (HNSCC), mediating cell survival signaling and resistance to radiation therapy.
despite the success of EGFR targeted therapies such as cetuximab, therapeutic resistance to EGFR targeting
ultimately develops. A significant challenge for improving EGFR targeted therapies is to identify and clinically
validate actionable mechanisms of therapeutic resistance. In this proposal, we have designed a strategy that
iterates between basic science investigations, preclinical testing, and clinical specimen testing to elucidate the
mechanism of cetuximab resistance in HNSCC. Using an in vitro approach for analyzing cetuximab resistance,
we identified upregulation of a targetable autocrine ligand, NRG-1, as a target mechanism of resistance. We
have modeled this resistance both in cell lines and in vivo, using mouse xenograft studies, and have shown
that it can be reversed therapeutically by using an ErbB3-targeted antibody therapeutic (CDX-3379) – which
can restore responses to cetuximab and radiation therapy. We have also observed NRG-1-induced resistance
to small molecule EGFR kinase inhibitors in cancer cells, and have studied the mechanistic origin of this
resistance at a structural level. We propose to exploit this new knowledge to advance small molecular
approaches for targeting EGFR family members in HNSCC. In parallel with these studies, we will study clinical
specimens from an ongoing phase II HNSCC trial of afatinib plus cetuximab, plus two ECOG trials of
cetuximab, to investigate resistance mechanisms in the clinic. We will also develop patient-derived xenografts
(PDX) models from the ongoing clinical trial to test hypotheses for resistance mechanisms and to assess
effectiveness of new strategies devised to overcome it.
The key premise of the proposal is that understanding mechanisms of resistance to cetuximab will open up
new therapeutic opportunities – allowing us to develop approaches that can still inhibit EGFR when cetuximab
fails, and to develop approaches to target other molecules that activate EGFR in a cetuximab-insensitive way
(such as ErbB3). Our three Specific Aims are:
1. To elucidate and model mechanisms of cetuximab resistance in HNSCC, and to test CDX-3379 as a new
ErbB3 targeted approach for enhancing systemic and/or radiation therapy in HNSCC.
2. To develop new structure/mechanism-guided strategies for successful ErbB-receptor targeting with small
molecule tyrosine kinase inhibitors (TKIs) in HNSCC.
3. To identify biomarkers of therapeutic response to ErbB-targeted therapies using clinical trial samples, and to
establish parallel patient-derived tumor models to evaluate mechanisms of resistance to ErbB-targeted
therapies in HNSCC.

Public health relevance
NARRATIVE A major challenge for improving the efficacy of EGFR targeted therapies (such as cetuximab) in HNSCC is to identify and address cellular mechanisms of therapeutic resistance. We have designed model systems at the molecular, cellular, and tumor levels to analyze cetuximab resistance and to test both antibody-based and small molecule-based therapeutic approaches that block this signaling axis. Combined with an analysis of cetuximab treated patient tumor samples, the overarching goal of this project is to evaluate mechanistically novel EGFR family-targeted treatments in preclinical models of HNSCC.